Digital Itap Supplement

Abstract
The goal of this initiative is to fast-track carefully selected clinical studies that can help address
the urgent healthcare issues created by the COVID-19 pandemic. The extent and urgency of the
situation requires an aggressive approach to accelerate the delivery of solutions to address
current needs. The proposed approach augments the strong technical, clinical and
commercialization expertise of CAPCaT to get needed solutions into practice within weeks to
months. This supplement will use a digital, site-less study approach to test the clinical
performance of new in vitro diagnostics for SARS-CoV-2. The Center for Advancing Point of
Care Technologies (CAPCaT) in Heart, Lung, Blood, and Sleep Diseases is an offshoot of a
highly successful medical product incubator, the Massachusetts Medical Device Development
Center (M2D2) at the University of Massachusetts Lowell and Medical School campuses. The
founding goal of M2D2 was to accelerate the development of medical devices, combining the
engineering and business expertise of UMass Lowell (UML) with the clinical expertise of UMass
Medical School (UMMS) in Worcester. CAPCaT, along with M2D2, has a network of industry
partners and funders to support the development and commercialization of promising
technologies. Among our industry partners are Johnson & Johnson, Boston Scientific, Amgen,
and Hologic. CAPCaT is one of four Point of Care Technology Research Network (POCTRN)
Centers (Emory/GA Tech, Northwestern, and Johns Hopkins University house the others).
CAPCaT has worked with the other POCTRN Centers and its Coordinating Center (CIMIT-Mass
General Hospital) and our scientific and program officers at NHLBI and NIBIB to review the
situation and to understand unmet needs and resources accessible by the network that can
make a difference.

Public health relevance
Program Narrative Scalable, inexpensive, and accurate point of care technologies for the detection of SARS-CoV-2 are desperately needed. Understanding performance characteristics and usability in a variety of populations and settings is critical to the process of developing these new technologies. This supplement will use a digital, site-less study approach to test the clinical performance of in vitro diagnostics for SARS-CoV-2.